The role of Tau in mediating the effects of abeta(1-42) on the parathyroid gland in primary hyperparathyroidism

ABSTRACT
Vitamin D deficiency is a widespread problem among the elderly and can precipitate sequelae that are
particularly harmful to this vulnerable population. Hyperparathyroidism (HPT) is commonly associated with low
vitamin D status, and the disruption in calcium homeostasis that is the cardinal feature of this disease can lead
to a range of deleterious outcomes among the elderly, including loss of bone density, muscle weakness, and
increased risk of falls and pathological fracture. As the primary endocrine organs responsible for hormonal
control of serum calcium levels, the parathyroid glands are a known target for the actions of vitamin D, yet there
are major gaps in our understanding of how vitamin D deficiency and attenuated vitamin D receptor (VDR)
signaling contribute to the etiology and clinical presentation of HPT. The mechanistic intermediates linking the
VDR to parathyroid hormone (PTH) hypersecretion in HPT remain unknown, and the current model of VDR-
dependent expression of the calcium sensing receptor (CaSR) in the parathyroid does not account for the
significant proportion of HPT cases where downregulation of CaSR abundance in parathyroid tissue is not
observed. Recently, several key findings from our group suggest a testable new model for vitamin D-mediated
actions in the parathyroid gland. First, we showed that the GABA B1 receptor (GABAB1R) can form heterodimeric
complexes with CaSR, promoting tonic hypersecretion of PTH by opposing the coupling of CaSR with its obligate
downstream G-protein effectors Gq/11 and Gi. Second, building upon a recent report demonstrating that soluble
peptide derivatives of the amyloid precursor protein (APP) can bind and activate GABAB1R in neurons, we found
that the APP-derived peptide Aβ1-42 can increase maximal PTH secretion by parathyroid tissue in a CASR- and
GABAB1R-dependent manner. VDR expression and serum vitamin D levels are inversely correlated with the
relative abundance of APP, Aβ1-42, the γ- and β-secretases required for Aβ1-42 production, and the phosphorylated
form of the microtubule associated protein Tau (pTau). Functionally, ablation of APP in the parathyroid
abrogates the development of HPT in VDR KO mice, and inhibitors of Tau phosphorylation can block the ability
of Aβ1-42 to promote PTH hypersecretion. These data suggest that HPT driven by loss of VDR activity could
arise at least in part through unregulated expression of Aβ1-42 and pTau. Based on these findings, we
hypothesize that aging-induced increases in Aβ1-42-mediated signaling drive tonic PTH hypersecretion and that
vitamin D deficiency exacerbates HPT disease severity by relieving suppression of Aβ1-42 production and
Tau/pTau expression. To test this model, we propose three complementary, mechanistic specific aims: (1) to
delineate the molecular actions of Aβ1-42 on CaSR, GABAB1R, and downstream signaling events that promote
PTH hypersecretion; (2) to determine whether blocking the production or activity of Aβ1-42 and Tau delays HPT
development in a murine model of CaSR insufficiency; and (3) to delineate the causal relationship between VDR
and Aβ1-42/pTau signaling in the parathyroid. By defining the contributions of the CaSR/GABAB1R/Aβ1-42
signaling axis to PTH hypersecretion, this work will provide a clearer mechanistic understanding of the
unexpected connection between β-amyloid peptides, vitamin D status, and parathyroid gland function.

Public health relevance
PROJECT NARRATIVE This study seeks to examine a previously unrecognized connection between the vitamin D receptor, the beta- amyloid peptide signaling, and hyperparathyroidism, an increasingly common disease of calcium metabolism. Because hyperparathyroidism disproportionately affects the elderly and causes a spectrum of clinical problems like bone density loss that are particularly burdensome to this vulnerable population, effective treatment strategies are urgently needed. Upon successful completion of the project, we will understand how the vitamin D receptor and amyloid peptides affect hormonal pathways essential for regulating calcium levels in the body. Results from this work will open new avenues for therapeutic intervention to restore and maintain normal bone and mineral health in the elderly.